Federal and State Integration Activities toAdvance Cooperation and Regulatory StandardsAmong Animal Food Safety RegulatoryPrograms

PROJECT SUMMARY
Project Title:
Federal and State Integration Activities to Advance Cooperation and Regulatory Standards
Among Animal Food Safety Regulatory Programs
Project Objectives:
As outlined in the requirements for RFA-FD-25-022, the primary objectives for this
proposed project are for the NASDA Foundation (NASDAF) and AAFCO to:
1) Support the advancement of the AFRPS and future revisions of the AFRPS as part of
a system of continuous improvement to ensure the standards are modernized and
support the needs of animal food regulatory programs;
2) Identify, develop, deliver, promote, and assist with attendance of animal food safety
training programs to support implementation of AFRPS, as well as training and
stakeholder support for provisions of FSMA;
3) Support the eQorts of federal and state government agencies to build and expand a
national integrated animal food safety system; and
4) Establish and improve existing systems for the sharing, promotion, and
collaboration of best practices, guidance documents, sampling plans, procedures,
memorandums of understanding, and other tools to facilitate and encourage
mutual reliance between federal and state animal food regulatory programs and
public health agencies.
Expected Outcomes:
The work outlined in this proposal will continue to build upon past successes achieved by
the collaboration between national associations and state and federal partners over the
past ten years, resulting in continuous improvement of the national integrated animal food
safety system and increased compliance with the AFRPS. Additionally, by working under a
single cooperative agreement, administrative cost savings will be realized by FDA, NASDAF,
and AAFCO.

Public health relevance
Project Narra+ve Under an ini)al 3-year coopera)ve agreement from FDA, considerable progress was made toward moderniza)on of the na)onal animal food safety system as envisioned by the Food Safety Moderniza)on Act (FSMA). The work outlined in this project proposal will con)nue the important joint eﬀorts of AAFCO, NASDA, and FDA as they work together on con)nuous improvement of the na)onal animal food safety system, promo)on of the Animal Feed Regulatory Program Standards (AFRPS), and a stronger mutual reliance between state and f ederal partners. Budget: $600,000 per year for three (3) years, totaling $1,800,000